Microneedle-mediated expansion of skin-resident regulatory T cells for management of autoimmune skin diseases

Project Summary/Abstract
Disorders in the regulatory arm of the adaptive immune system can result in autoimmune skin diseases (ASDs)
such as Alopecia Areata (AA). Janus Kinase (JAK) inhibitors are the only FDA-approved approach for severe
AA, yet their immunosuppressive nature carries the risk of heightened susceptibility to infections and
malignancies. These systemic side effects deter their use for patients with focal or mild-to-moderate AA as the
risks outweigh the benefits. Moreover, they only offer temporary symptom relief, largely due to their suppression
of regulatory T cells (Tregs), which may explain the high relapse rates (>80%) observed clinically after therapy
discontinuation. Tregs are critical for maintaining immune tolerance, even more in the context of AA, where the
depletion of skin-specific Tregs has been demonstrated to trigger inflammation in the hair follicles (HFs) and
alopecia. Hence, localized therapies that selectively expand Tregs, instead of suppressing them, are urgently
needed. The LybraPatch©, a hydrogel-based microneedle (MN) patch, offers a revolutionary solution by
delivering Treg-expanding cytokines, IL-2 and CCL22, directly at the site of autoimmunity. This targeted approach
minimizes systemic exposure while restoring immune homeostasis. We have demonstrated in a murine model
of immune-mediated AA that the LybraPatch promotes significant Treg expansion and reduction of pro-
inflammatory cues, leading to hair regrowth and reversal of the symptoms for weeks beyond treatment
discontinuation without inducing systemic immunosuppression. In order to advance towards IND-enabling
studies, it is now essential to further define the optimal IL-2 dosage ensuring selective Treg expansion without
activating pro-inflammatory effector T cells (Teffs) since IL-2 can lead to their synchronous activation if delivered
in higher dosages. Here, we first aim to define the maximum tolerated dosage (MTD) of IL-2 leading to systemic
Treg expansion in a murine model of AA via pharmacokinetic (PK) analyses. Specifically, the local and systemic
concentration of IL-2 will be measured following the administration of the patch. Next, we will perform
pharmacodynamic (PD) studies to evaluate the effects of various IL-2 doses on the skin’s immune environment,
focusing on Treg expansion and Teff activation using flow cytometry. By the conclusion of this work, we will
establish the precise IL-2 dosing parameters and therapeutic window that balance safety and efficacy,
establishing a data package to support our upcoming IND-enabling studies. Our work will address a critical gap
in ASD treatment landscape for focal patients (accounting for more than 90% of all patients) that still lack FDA
approved treatments. The LybraPatch promises to offer a localized, minimally invasive therapy that targets the
root cause of immune dysregulation while avoiding systemic risks. This work lays the foundation for safer and
more effective treatments, advancing the clinical translation of localized immunomodulatory strategies for ASDs.

Public health relevance
Project Narrative The proposed research aims to define the optimal IL-2 dosage for regulatory T cell (Treg)-centric immunomodulation using the LybraPatch©, our proprietary hydrogel-based microneedle (MN) patch developed for the treatment of autoimmune skin diseases (ASDs) such as Alopecia Areata (AA). This work addresses the critical challenge of balancing IL-2’s therapeutic potential to expand Tregs while avoiding the concurrent activation of effector T cells (Teffs) and systemic immunosuppression, a known limitation of IL-2 therapies. By identifying a precise therapeutic window through pharmacokinetic and pharmacodynamic studies in a murine models of AA, we aim to establish a safe and effective dosage and advance this localized, skin-targeted therapy towards IND- enabling studies.